Uptake2 transporters: Novel sex-dependent molecular targets to treat stimulant use disorder

Medications to treat substance use disorders (SUD) exist for many drugs of abuse, but not for psychostimulants,
such as amphetamine (AMPH), and methamphetamine. They are also lacking for increasingly used synthetic
drugs designed to mimic the actions of known psychostimulants. Both known and new psychoactive substances
continue to pose a major and increasing public health threat. To develop effective treatments, the mechanisms by
which these stimulants produce their abuse-related effects need to be better understood. Many stimulants interact
with the dopamine (DA) transporter (DAT), which is thought to mediate their abuse-related effects. However,
strategies targeting DAT have yielded little to no benefit in the treatment of psychostimulant addiction, raising the
possibility that these stimulants have significant actions elsewhere to modulate dopaminergic neurotransmission.
Consistent with this, a rapidly growing literature supports a prominent role for organic cation transporter 3 (OCT3)
in regulating dopaminergic neurotransmission. Our preliminary data support this idea, showing that decynium-22
(D22), an inhibitor of OCT3, inhibits DA release in vivo in male OCT3 wild-type (WT) mice, an effect lost in
constitutive OCT3 knockout (KO) mice. Furthermore, in vitro studies showed that AMPH-induced substrate efflux
could be inhibited by D22 in a manner independent of cocaine-sensitive transporters. These finding were paralleled
by a loss of conditioned place preference (CPP) for AMPH in male mice, and an attenuation in female OCT3 KO,
with D22 preventing CPP in both WT sexes. Preliminary data in male mice show that the dose-response curve for
self-administration of AMPH is dramatically downward and rightward shifted in male OCT3 KO mice relative to their
WT counterpart. In light of these findings, we have established and validated OCT3 floxed mice so as to examine
the role of OCT3 in the absence of any developmental compensation that may occur in germline KOs. Harnessing
the power of these mice, new data show that tamoxifen inducible or viral KO of OCT3 robustly attenuates AMPH-
evoked DA release and CPP. Proposed studies will interrogate OCT3’s role in the ability of AMPH to impact
behavior and DA efflux by testing the novel and potentially transformative hypothesis that AMPH driven DA release
is not mediated solely by DAT but by reverse transport via OCT3 as well. Thus, DAT-OCT3 redundancy may
explain why DAT-based therapeutics have been unsuccessful in treating AMPH use disorders. We will use a
combination of pharmacology, novel and established transgenic mouse models (DA neuron-specific vs glia-
specific), and brain-region specific viral knockdown, to determine the role of OCT3 in AMPH-induced behavioral
effects (locomotion, rearing, stereotypy, sensitization, CPP, self-administration) (Aim 1), and AMPH-induced DA
efflux and clearance in vivo (Aim 2). In Aim 3 we will determine how tamoxifen inducible KO or viral KO of OCT3
impacts key elements in DA signaling and how OCT3 adapts to chronic AMPH self-administration. These studies
will fill fundamental knowledge gaps about the importance of OCT3 in abuse-related effects of AMPH, and its
congeners, which will help identify novel molecular targets for medications to treat AMPH addiction.

Public health relevance
Medications to treat addiction exist for many drugs of abuse, but not for amphetamine-type stimulants, which include amphetamine, methamphetamine and the increasingly popular new psychoactive substances such as synthetic cathinones, also knowns as “bath salts” and “legal highs”. Amphetamine-type stimulants are among the most commonly abused, afflicting approximately 56 million people between the ages of 15 and 64 worldwide, creating a major public health burden, and underscoring a vital need to find effective treatments. Proposed studies will explore a previously unknown mechanism of action of amphetamine-type drugs, with the goal to identify and validate organic cation transporter 3 as a novel target for the development of effective treatments for amphetamine-type stimulant abuse.